MHC TYPING FOR AIDS RESEARCH

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To offer MHC typing of the MHC class I and II loci for investigators working with macaques (Indian rhesus, Chinese rhesus, [unreadable] and Cynomolgus). To adapt technologies for HLA typing to molecular typing of macaque (Indian rhesus, Chinese rhesus, [unreadable] and Cynomolgus) MHC class I and II.[unreadable] [unreadable] The increased utility of various species of macaques as animal models in both HIV vaccine development and pathogenesis [unreadable] studies necessitates the continuation of reference MHC typing laboratories for these species. We plan to continue to offer [unreadable] services to both the North American and European scientific communities for MHC typing of macaques. Initially, this will [unreadable] include PCR-SSP tests for alleles encoding MHC class I and II molecules that bind peptides derived from SIV and SHIV. We [unreadable] are developing additional molecular techniques for analysis of the Indian rhesus and Chinese rhesus and Cynomolgus [unreadable] macaque MHC class I and class II alleles. Additionally, we offer training for individual laboratories that wish to set up MHC [unreadable] typing. Finally, we are developing a panel of well-characterized cell lines that will be invaluable for [unreadable] the analysis of the MHC in the macaque. In 2004, we tested 1,684 macaque blood samples for 95 external investigators [unreadable] and WNPRC scientists, performing 14,070 tests. To date, we have typed more than 6,807 macaques for over 100 [unreadable] investigators, performing 50,074 tests. These typings have supported the publication of over 50 manuscripts. In 2004 and [unreadable] 2005, we successfully submitted a competitive renewal for this grant. In 2006, we have performed over 9,500 [unreadable] genotyping reactions, serving approximately 20 independent principal investigators from over 10 different institutions. In [unreadable] addition, we have developed and are preparing to offer expanded services, which include typing specificities for a total of 22 [unreadable] Class I and 17 Class II alleles of the Indian rhesus macaque. This research used WNPRC Immunogenetics & Virology [unreadable] Services.